Pathogenesis of Calcium Nephrolithiasis

DESCRIPTION, OVERALL.......................................................................................................................3

Public health relevance
RELEVANCE (See instructions): Studying kidney physiology and kidney tissues from the same patients can give new insights into how stones and crystals form in kidneys. Kidney stones are a common and costly disease in the US; a greater understanding of causal mechanisms will eventually improve diagnosis and treatment.